FIU-Diversity Center for Genomic Research (FIU-DCGR)

FIU Diversity Center for Genomic Research (FIU-DCGR)
Abstract
Florida International University (FIU) is in Miami-Dade County, Florida, a county with a population of 2.7 million
(2020) in which 69% are Hispanic Americans and 17% are African Americans. FIU is a federally designated
Hispanic-Serving Institution (HSI) and Minority-Serving Institution (MSI). FIU is the largest HSI in the
continental U.S. and one of the largest MSIs. As one of the top 10 largest universities, FIU has over 56,000
students (2020), with 79% underrepresented minorities (URMs) and more than 1,100 full-time instructional
faculty. FIU plays an important role in supporting scientific research, particularly on diseases such as HIV and
mental illness that disproportionately impact racial/ethnic minorities that often experience health disparities.
FIU has a mission to serve historical URMs in biomedical research. Researchers at FIU are uniquely
positioned to bring novel perspectives and broaden the field of genomics, e.g., by engaging URMs in research
and helping to translate research advances into measurable and sustained improvements in health outcomes
for underserved communities. However, research depth is restricted due to insufficient capacity to conduct and
sustain cutting-edge health-related research, especially genomic research. To address health disparities,
increase representation in genomic research, provide culturally responsive care, foster community
engagement and trust, promote workforce diversity, and improve access to genomic medicine for minority
populations, we propose to build the FIU Diversity Center for Genomic Research (FIU-DCGR) at FIU. There
are two Phases in building the center: 1) During Phase I (UG3), we will develop plans and test the feasibility of
achieving the primary goals to enhance diversity in genomic research by establishing FIU-DCGR to carry out
innovative, state-of-the-art genomic research studies; foster genomic research career development and
enhancement for trainees and investigators at all career levels; enhance the genomic infrastructure,
computational, analytical and ethical, legal, and social implications (ELSI) of genomic research capability;
establish sustainable partnerships and disseminate resources and findings. 2) During Phase II (UH3), we will
build the genomic center, which is expected to support an Administrative Core, Workforce Development Core,
Community Engagement Core, and three interrelated, innovative research projects. Outcomes from FIU-DCGR
will be: 1) the genomic research capacity will be significantly increased at FIU, resulting in more genomic-
related research be performed; 2) the diversity and scale of the genomics research workforce at FIU will being
carried out; 3) innovative ideas and creative thinking in genomic studies will be developed; and 4) the genomic
research interests among URM students as well as the participation of URMs and underserved communities in
genomic studies will be enhanced reducing health disparities.

Public health relevance
Project Narrative This project aims to build a Diversity Center for Genome Research at Florida International University (FIU), which is the largest federally designated Hispanic-Serving Institution in the continental U.S. and one of the largest Minority-Serving Institution (MSI). The objectives of this proposal are consistent with the goals of the NIH full-scale Diversity Centers for Genome Research (DCGR) program and will have a significant impact on public health by providing cutting-edge genomic research projects, capacity building, and training in genomics at FIU. This multi-departmental project conducted by a diverse team of highly educated and experienced specialists will provide training and scholarship opportunities to 24 dual enrollment, undergraduate and masters students; training and graduate assistantships to 10 doctoral students; and pilot project grants to 15 early-stage investigators (assistant professors or postdoctoral fellows).